Engineering Biologics for treatment of enteric diseases

Abstract
Enteric diseases, including both acute and chronic diarrhea and constipation, are among the most common
ailments afflicting humans. Many enteric diseases, such C. difficile infection (CDI) and inflammatory bowel
disease (IBD), are currently treated with systemically delivered biologics (e.g. bezlotoxumab for CDI and anti-
TNF antibodies for IBD). However, since the GI lumen is also home to trillions of microbes that may cause
sepsis if present in the blood, the GI tract has evolved over millions of years to strictly prohibit the diffusion of
large molecules, such as proteins and peptides, between the GI lumen and the blood circulation. Consequently,
the GI lumen is not readily accessible to systemically delivered biologics. In addition to reduced potency due to
poor access, the treatment of enteric diseases with systemically delivered biologics also suffers from additional
drug side effects due to the systemic exposure. We posit that orally delivered biologics, whose bailiwick is mostly
confined within the GI lumen, would likely be much better suited for treating enteric diseases due to both
increased local drug concentration and reduced systemic side effects. Unfortunately, since the primary function
of the GI tract is food digestion, conventional biologics are unlikely to be fully active in the protease-rich
environment of the GI lumen. In this project, we propose to develop both a protease-stable protein scaffold and
a delivery platform custom-made for biologics-mediated treatment of enteric diseases. These studies will exploit
an in vitro protein display technology recently developed in our lab that covalently links the displayed protein to
its coding cDNA in a one-pot reaction. We will first employ directed evolution to enhance the protease stability
of a designed ankyrin repeat protein (DARPin) (Aim 1). Concurrently, we will develop a probiotic yeast platform
for in situ delivery of protease-stable DARPins to the GI tract (Aim 2). Finally, using CDI as a model enteric
disease, we will perform preclinical development of a toxin-neutralizing and protease-stable DARPin and
evaluate its efficacy in vivo (Aim 3). Successful completion of this project should bring forth both a novel protease
stable protein scaffold and an efficient in situ protein delivery platform, and may greatly accelerate the
development of biologics against diverse enteric diseases.

Public health relevance
Narrative Enteric diseases are among the most common human ailments. Conventional biologics are not suited for enteric applications due to their susceptibility to degradation in the protease-rich environment of the GI tract. This project will develop both a protease-stable scaffold that can be templated for engineering biologics for diverse enteric diseases and a probiotic yeast-based platform for in situ delivery of biologics to the GI lumen.